Project 3 - Immune analysis of clinical trial samples

Project 3. Immune Analysis of Clinical Trial Samples.
Abstract
The reasons for the lack of therapeutic success of CAR therapy for solid tumors, compared to that seen
in hematologic malignancies, represents one of the most important questions in the field of immunotherapy.
Programs that can integrate clinical trials (Project 1), preclinical studies (Project 2) and in-depth biocorrelate
studies of samples derived from these human trials (this Project) are needed. As described in Project 1, our
new clinical trial will use an optimized mesothelin targeted CAR, M5 huCART-meso, that has been
constructed to contain a new anti-mesothelin scFv fragment that it is fully human (selected from a phage
display library). M5 huCART-meso also had better preclinical efficacy than our previous SS1-mesothelin CAR
(see Project 1). Our second planned clinical trial will use a CAR, huCART-FAP, directed to fibroblasts in tumor
stroma by targeting fibroblast activation protein (FAP). The goal of Project 3 is to conduct biocorrelate studies
of these clinical trials. We will focus on two main areas. In Aim 1, we will conduct studies to learn whether our
CAR T cells in Project 1 are persisting and trafficking to tumors. We will analyze blood samples from our
patients in Core B, however, we hypothesize that studying the ability of CARs to traffic to tumors is even more
critical. CAR T cells isolated from tumor biopsies will be characterized for phenotype and function. In addition,
the tumor will be examined for histological changes, target antigen expression, and transcriptionally profiled.
Post-treatment biopsies will be expected from each patient in the trials proposed in Project 1 helping to ensure
that materials from tumors are available for such studies. In Aims 2 and 3, we will conduct experiments aimed
at studying epitope spreading which is a crucial, yet an understudied area of adoptive T cell transfer. In Aim 2,
we will evaluate the hypothesis that the CAR T cells used in our clinical trials can enhanced/promote
endogenous T cell immunity to shared tumor antigens (Aim 2A) and neoantigens (Aim 2B). In Aim 2A,
overlapping peptide libraries from known tumor antigens as well as defined peptides will be used to interrogate
PBMC for responses to shared tumor antigens. In Aim 2B, we will use next generation sequencing (NGS) of
tumors to identify candidate neoepitopes. Tandem mini-gene constructs, as well as synthetic peptides
encoding these neoepitopes, will be used to interrogate peripheral blood (and in limited cases, TIL) for new or
enhanced T cell immunity after CAR therapy. Aim 2 in Project 3 is linked to Aim 2 in Project 2, where
investigators will use animal models to look for the presence of antigen spreading and ways to augment this
effect. Finally, in Aim 3 we will examine the hypothesis that CAR-mediated epitope spreading promotes a
diverse repertoire of antigen-specific T cell responses in tumors by utilizing NSG methods to characterize TCR
clonotypes in shared/neoantigen-specific T cell lines derived from blood. These TCR reference libraries will be
employed to interrogate pre- and post- CAR T therapy in blood/tumor biopsy samples in order to characterize
the intra-tumoral breath and composition of T cell immunity promoted by CAR-mediated epitope spreading.

Public health relevance
Project 3. Immune Analysis of Clinical Trial Samples. Narrative The goal of this Program Project is to successfully implement the use of a new form of immunotherapy called adoptive T cell transfer using chimeric antigen receptors (CARs), to treat thoracic cancers. The goal of Project 3 is to conduct human biocorrelate studies to learn whether the infused CAR T cells in Project 1 are: (1) persisting and trafficking to tumors and (2) whether these CAR T cells can induce endogenous adaptive immune responses, thus amplifying their effects. These results will ultimately allow us and others to design better clinical CAR T cells trials for solid tumors.